Cis-regulatory circuitry underlying Hedgehog mediated limb development

Dysregulation of Hedgehog (HH) signaling is linked to catastrophic birth defects in infants and is an underlying
cause of the structural defects in a range of syndromes, including ciliopathies. The effects of HH signaling are
primarily mediated through de-repression of target genes, but the mechanisms by which GLI proteins act as
transcriptional repressors remain poorly understood. Recently, we found that GLI repressors prevent
transcription of target genes by deactivating their own enhancers through chromatin-based histone
deacetylation. We then found that GLI3 is present but apparently inert in early limb buds before the onset of
HH signaling. We hypothesize that GLI repression is normally regulated by the expression of co-repressors
rather than being the default state occurring in the absence of HH signaling. In Specific Aim 1 we will
determine how GLI3 repressor activity is inactive prior to the onset of Hedgehog signaling. We will determine if
GLI repression is inert because of sub-threshold protein kinase A activity or, alternatively, if it is triggered by
the onset of HH expression. In parallel, we will determine if the lack of GLI3 repression is due to an unexpected
early redundancy with GLI2. These findings will determine whether HH pathway members trigger GLI
transcriptional repression. In Specific Aim 2 we will determine how GLI transcriptional repression regulates
chromatin accessibility. GLI transcriptional repression causes both reductions in H3K27 acetylation as well as
reductions in ATAC-seq accessibility at GLI enhancers. We will determine if the reduced accessibility occurs
because of changes in nucleosomal density or because of reduced histone acetylation. Additionally, we
hypothesize that GLI3 transcriptional repression occurs through the NuRD complex, which uniquely contains
both the HDAC and chromatin remodeling activities that are observed with GLI3 repression. Our preliminary
data supports this hypothesis, indicating that GLI3 binds to CHD4, a component of the NuRD repressor
complex that mediates nucleosomal sliding. The results will provide a mechanistic understanding of how GLI
transcriptional repression controls chromatin accessibility to regulate HH target gene expression. In Specific
Aim 3, we will identify co-factors regulating GLI repressive activity. We hypothesize that GLI repression occurs
through the recruitment of an unknown co-repressor complex containing HDAC activity. We will test several
ranked candidate co-factors by determining if they bind to known GLI enhancers and if this binding is reduced
in limb buds lacking GLI3. In a complementary, unbiased approach, we will identify factors that bind to GLI3
on chromatin using an endogenously biotinylated GLI3 allele. The identification and subsequent validation of a
co-factor(s) mediating GLI repression will fill a major gap in our understanding of how HH signaling regulates
gene expression. Overall, these results will be impactful in illuminating a novel layer of HH pathway regulation
as well as enabling a mechanistic understanding of GLI transcriptional regulation that will be applicable to
understanding the full biological spectrum of HH-mediated responses.

Public health relevance
Project Narrative: Defects in the Hedgehog signaling pathway underlie a vast spectrum of human birth defects, including ciliopathies, holoprosencephaly, cleft palate, and a variety of limb defects such as polydactyly. This proposal seeks to fill a fundamental gap in our understanding of Hedgehog signaling regulates gene expression through the GLI proteins. It will determine how the activity of GLI proteins is regulated to repress the expression of HH target genes and which other proteins are required for this activity.